7 Tesla Small Animal MRI for Translational Research

The Magnetic Resonance Research Center (MRRC) is a multi-disciplinary and multi-
modality research facility within the Albert Einstein College of Medicine (Einstein). The facilities
within the MRRC are 100% available for clinical and basic research to all investigators within the
Albert Einstein College of Medicine and Montefiore Medical Center. The mission of the MRRC
is to support research into numerous diseases and disorders being conducted by a large
population of basic and clinical scientists within the Einstein program who are engaged in
translational research. These efforts require turnkey, state-of-the-art imaging instrumentation to
make best use of noninvasive functional, structural and spectroscopic imaging in their research
investigations.
At Einstein, translational research is a key focus of the scientific and clinical community.
Several centers, including the Institute for Clinical and Translational Research, the Einstein
Caner Center, the Einstein Diabetes Center and the Institute for Developmental Disabilities
Research Center are focused upon promoting multidisciplinary collaboration, addressing
translational 'blocks' in research, providing infrastructure and collaborative support, and
enhancing training, education, and career development. All these centers have independent
investigators that utilize the MRI imaging resources available in the MRRC.
Einstein and the Department of Radiology have recently purchased and installed a fully
digital 3.0 Tesla multinuclear Philips Elition for human MRI research in the MRRC. However,
the MRRC animal imaging program is currently supported by an aging and obsolete 9.4 T MRI
system, in dire need of replacement.
The Specific Aim of this proposal is to make possible the acquisition of a research
dedicated, state-of-the-art 7.0 Tesla small animal magnetic resonance imaging and
spectroscopy system. This system will support ongoing translational NIH-sponsored research
into cancer, diabetes, aging, rare diseases, epilepsy, brain trauma and many other areas of
active research within the Einstein community. Einstein and the Department of Radiology will
continue is unwavering support of the MRRC infrastructure, and will provide resources for
installation. Einstein is committed to the successful application of non-invasive imaging
research taking place throughout the entire medical school program.

Public health relevance
This proposal provides for purchase of a high field (7.0 Tesla) small animal magnetic resonance imaging and spectroscopy system to support ongoing translational research at the Albert Einstein College of Medicine of Montefiore Medical Center. The instrument will be located within the medical school along with small animal PET/SPECT/CT equipment and human MRI research instrumentation, facilitating translational investigations into many diseases affecting the human condition. The instrument will support research into mechanisms of cancer metastasis, diabetes, cerebral malaria, rare diseases, leukodystrophies, brain trauma, epilepsy, sickle cell and other diseases.